Molecular Mechanisms of Disease

Project Summary
This proposal seeks funding to continue support for the Molecular Mechanisms of Disease (MMoD)
predoctoral training program at the University of Nebraska-Lincoln. The MMoD program addresses the NIH
training focus of Cellular, Biochemical, and Molecular Sciences by providing advanced training and career
development in biomedical research centered on molecular interactions and chemical transformations. The
goal of the program is to develop outstanding new scientists who work in collaborative multi-disciplinary
teams to research disease mechanisms using quantitative approaches that ultimately yield tangible
strategies for prevention and therapy. To accomplish this goal, the program recruits high-quality, motivated
predoctoral trainees with a strong interest in the underlying causes of human disease and engage them in
mentored, cutting-edge research. Program outcomes from the last four years indicate strong progress
toward our goal with 17 appointed trainees thus far. The MMoD program provides collaborative training in
mechanistic disease research in the areas of molecular signaling, metabolic integrity, oxidative stress and
redox biology, and disease microenvironment. The mentoring team spans seven departments and three
colleges and includes 32 faculty members from early-stage to established investigators with strong histories
in biomedical research funding and graduate student mentoring. The MMoD program will (1) Provide a
rigorous curriculum and innovative, collaborative research opportunities for six predoctoral trainees per year
(NIH-supported) to become experts in the mechanistic study of human disease; (2) Cultivate an interactive
and inclusive training environment that enables trainees to develop professional skills in communication,
leadership, proposal-writing, scholarship, entrepreneurship, and teaching; and 3) Build a cohort of trainees
from diverse perspectives that have the knowledge and ability to work at the crossroads of different
disciplines in their future careers as PhD scientists. Trainees will conduct research rotations in year 1 before
choosing a faculty mentor, and will be supported by NIH T32 funding for up to two years beginning in their
second year of their five-year program. Selection of new trainees for NIH support will be competitive and
includes an original collaborative proposal bridging disciplinary boundaries for innovative thesis research.
Trainees will take a flexible core curriculum that emphasizes writing and quantitative biology skills. Students
in the MMoD program acquire skills in evidence-based education, quantitative and critical analysis, and rigor
and reproducibility in research. They also gain professional experiences related to intellectual property and
the pharmaceutical industry in preparation for potential career options. The MMoD program provides a
framework that enables trainees to gain a broad knowledge base; actively seek research collaborations;
produce an outstanding record of original published research; and develop presentation, proposal-writing,
and leadership skills that position them for future excellence as independent researchers.

Public health relevance
Project Narrative Understanding how normal processes in the cell operate incorrectly at the molecular level during disease initiation and progression is vital to develop strategies to control disease. Interdisciplinary research that integrates methodologies across traditional fields is needed to advance the definition of molecular processes. The predoctoral program in Molecular Mechanisms of Disease at the University of Nebraska- Lincoln provides collaborative research projects, student-centered teaching, and diverse career development opportunities to develop a workforce of team-oriented scientists with critical expertise in the interdisciplinary study of disease progression.